Novel role of melanin-carbonyls in progression of NRAS mutant melanoma

We discovered melanin-chemiexcitation (MeCh) where Nitric oxide synthase (NOS) oxidizes melanin into
Melanin-carbonyls (MCs) that have triplet energy equivalent to a UV photon. The MCs generate ~50% of the
total cyclobutane pyrimidine dimers (CPDs), UV specific DNA adducts, in complete absence of UV. The
chemical events that conspire during and after MeCh, and specifically the role of MCs remain unknown in
melanoma. We propose to identify and characterize the role of melanin-carbonyl-DNA (MCD) and melanin-
carbonyl-protein (MCP) adducts in melanoma progression and resistance against current therapeutic
approaches. The rationale is that NOS is mostly hyperactive, and associated with poor prognosis of melanoma
patients, and the role of pigmentation is still controversial in melanoma. We hypothesize that high NOS induces
MeCh, leading to chronic MC production which dysregulates melanocytic physiology, and promotes melanoma
progression and therapy resistance through “MCD and MCP adducts” or other unknown mechanisms. The
hypothesis relates to three unique arms in melanoma. First is pigmentation. Melanin promotes melanoma by
activating HIF-1α. Contrarily, melanin’s physical existence inhibits metastasis through elasticity modulations,
but remains to be tested stringently. Second is MeCh which is proposed to be a central axis in melanoma
biology though never tested experimentally. Third is the NOS enzyme, hyperactive in melanoma, correlates
strongly with poor prognosis, and exclusively associated with melanin. Integrating these three arms with the
mechanisms operated by MCD and MCP adducts, we will identify a positive loop in melanoma that is steered
by NOS, MeCh, and MCs in the following two aims: In aim 1, we hypothesize that owing to hyperactive NOS,
the chronic MC production leads MCD and MCP adducts. Labeling the cellular melanin using click-chemistry-
analogs (CCA) of melanin-monomers (protocols established), we will induce MeCh chemically or with UV and
purify and characterize CCA labeled genomic and proteomic fraction using HPLC-MS/MS. Focus will be on
CPD hotspots in the genome and Lysine and Cysteine rich proteins from proliferative melanoma signaling
since -NH2 and -SH groups are prime targets for carbonyl adduction In aim 2, we hypothesize that MCD and
MCP adducts promote melanoma progression and therapy resistance. We sensitized patient derived
melanoma cells to targeted therapies by scavenging carbonyls and inhibiting NOS. Analyses across
melanocytes, dysplastic nevi, and melanoma, and the self-established pigmented and non-pigmented, patient
derived melanoma cells will identify probable mechanisms behind this sensitization which in our preliminary
observations, was independent of the driver mutations like BRAF or NRAS. An integrated analysis of Aim 1
and 2 will identify MC-mediated, non-classical regulation of melanoma progression and therapy resistance that
could be used as a novel vulnerability against melanoma.

Public health relevance
Project Narrative We discovered melanin-chemiexcitation which generates DNA adducts called cyclobutane pyrimidine dimers (CPD) in absence of UV and melanin-carbonyls as a side product. The aim of this proposal is to identify and characterize the melanin-chemiexcitation generated, melanin-carbonyl-DNA (MCD), melanin-carbonyl-protein (MCP), and DNA-DNA (CPD) adducts in pigmented melanocytes and keratinocytes. An integrated analysis of the MCD, MCP and CPD adducts and their physiological consequences will provide a better understanding of the skin homeostasis and strategies for skin cancer prevention at an early stage.